Elucidating the logic of proprioceptive networks

Project Summary/Abstract:
We interact with our world using precise and controlled movements. Models of motor control
incorporate the idea that the body must have a representation of its internal state to generate either a desired
trajectory (feedforward) or to compare with for the completed trajectory (feedback). This body map of the
internal state is produced using proprioception, the sense of limb and body position, yet it is not well
understood how this sense is generated or how other sensory inputs such as cutaneous (touch) information
feed into the proprioceptive sense. Loss of primary proprioceptive sensory neurons leads to severe motor
defects, indicating that proprioception is essential for motor function, and studies of the loss of cutaneous
sensory nerve inputs shows that touch information is needed for complex motor behaviors.
Early studies in cats suggest that at least some of the integration of proprioceptive and cutaneous
information happens at the level of cerebellar-projecting neurons in the spinal cord (spinocerebellar neurons).
These studies describe “proprioceptive” and “exteroceptive” (cutaneous/touch) subdivisions of the dorsal
spinocerebellar tract (DSCT) whereby subsets of neurons within this tract respond to either proprioceptive or
proprioceptive and cutaneous stimulation. However, at the time, it was difficult to differentiate between different
subsets of DSCT neurons. Current molecular lineage tracing technologies in mice are now able to differentiate
between different molecular subsets of the DSCT.
The goal of this proposal is to understand how proprioceptive and cutaneous information is organized
at the level of DSCT neurons in the spinal cord. We hypothesize that discrete molecular subsets of the DSCT
have distinct microcircuit connectivity important for their function in generating the proprioceptive sense and we
will test this hypothesis through the following Aims. Aim 1 will investigate the molecular and
electrophysiological diversity of DSCT neurons using deep sequencing technologies for the mRNA transcripts
of different subsets and recordings of specific neuronal subsets in acute spinal cord slices. Aim 2 will test
whether different subsets of the DSCT receive cutaneous and/or proprioceptive information using retrograde
transsynaptic viral tracing techniques. Aim 3 will examine if there are different spatial axonal trajectories of
DSCT neuronal subsets into the cerebellum to understand the spatial logic of their terminations using whole
tissue imaging technologies. Altogether, this proposal uses molecular, anatomical, and electrophysiological
approaches to elucidate the connectivity of DSCT neurons. This study will form the foundation for our long-
term goal of understanding how internal models of the body are constructed. The fundamental knowledge
gained from this study will impact the fields of somatosensation, motor control, and robotics as well as provide
insights into what kinds of neural circuits need to be regenerated upon spinal cord injury or neurodegenerative
disease states, such as Friedrich's ataxia.

Public health relevance
Project Narrative Precise and controlled movement is essential for us to interact appropriately with our world. This study will determine how the body generates an internal map of itself, which is necessary for proper motor function, by uncovering the circuits that underlie the sense of limb and body position (proprioception) at the level of the spinal cord. This fundamental knowledge will serve as the basis for understanding the proprioceptive circuitry underlying somatosensory biology and motor control in healthy individuals and athletes, their mimicry in robotics, recruitment of these pathways to produce sensations such as phantom limb, and their disruptions in degenerative ataxias, peripheral neuropathies, or traumatic injuries.